Improving Lipid Management Strategies in Young Adults

Low-density lipoprotein cholesterol (LDL-C) is a causative factor in the development of atherosclerotic
cardiovascular disease (ASCVD), and lipid-lowering therapy can markedly reduce this risk. Yet, when to begin
lipid-lowering therapy has not been well understood. Despite the increasing rates of ASCVD in US young
adults aged 18-39 years over the past two decades, use of lipid-lowering therapy remained low, with <7% of
young adults with LDL-C ≥160 mg/dL being treated (vs. ~50% in those aged ≥40 years). It is estimated that
52% US young adults have non-optimal LDL-C ≥100 mg/dL and 7% have LDL-C ≥160 mg/dL. However, there
is little evidence to guide lipid management in young adults. For risk assessment, current guidelines
recommend using the pooled cohort equations (PCEs) to estimate 10-year ASCVD risk to guide lipid-lowering
therapy. However, PCEs may not be directly applicable to young adults as they were developed in adults 40-
75 years of age. To address this issue, current guidelines encourage the estimation of 30-year or lifetime
ASCVD risk for young adults; however, these existing lifetime risk algorithms were derived from a single cohort
of non-Hispanic whites, which may limit their applicability to other populations and has been identified as a
limitation by current guidelines. Further, social determinants of health (SDOH) and other risk enhancing factors
known to increase ASCVD risk are not included in current risk assessment. For lipid management, the
benefits and harms of initiation of lipid-lowering therapy in young adults are unknown and are extrapolated
from trial data in older adults. Although randomized trials with hard ASCVD outcomes would provide definitive
evidence, it may not be feasible to perform such a trial in young adults due to high costs and long follow-up
time needed. In the absence of trials, high quality observational and simulation studies can provide clinically
relevant and actionable evidence for policy makers, patients, and clinicians.
To address these gaps, we proposes to study ~805,000 young adults from 4 cohort studies (CARDIA,
Framingham, HCHS/SOL, JHS) and Kaiser Permanente Southern California to (1) improve ASCVD risk
assessment accuracy for young adults by using data from contemporary and diverse populations, (2) quantify
the benefits and harms of lipid-lowering therapy among young adults by emulating a clinical trial using a large
observational database and state-of-the-art statistical models to minimize confounding and selection bias, and
(3) compare the population-scale health, economic, and health equity impact of alternative lipid management
strategies for US young adults identified in the current guidelines and Aims 1 and 2.
Findings from this study will inform future guidelines by identifying strategies for more effective lipid-lowering
and ASCVD prevention in young adults, reduce health inequity by directing treatment to high-risk subgroups
not currently prioritized including those with a high burden of SDOH, and improve cardiovascular health and
promote healthy aging of US young adults.

Public health relevance
Low-density lipoprotein cholesterol (LDL-C) is a causative factor in the development of atherosclerotic cardiovascular disease (ASCVD), and lipid-lowering therapy can markedly reduce this risk. Yet, exactly when to begin lipid-lowering therapy has not been well understood. Despite the increasing rates of ASCVD in US young adults aged 18-39 years over the past two decades, use of lipid-lowering therapy remained low, with <7% of young adults with LDL-C ≥160 mg/dL being treated (vs. ~50% in those aged ≥40 years). It is estimated that 52% US young adults have non-optimal LDL-C ≥100 mg/dL and 7% have LDL-C ≥160 mg/dL. However, there is little evidence to guide lipid management in young adults, partly due to the lack of empirical evidence. We propose to study ~805,000 young adults from 4 cohort studies (CARDIA, Framingham, HCHS/SOL, JHS) and Kaiser Permanente Southern California to identify more effective lipid-lowering and ASCVD prevention strategies and reduce health inequity in young adults.